Microfluidic tumor tissue processing platform for single cell diagnostics

ABSTRACT
Solid tumors are diverse ecosystems of different cell types, and this heterogeneity has been implicated as a
key factor driving disease progression, metastasis, and drug resistance. Increasingly, single cell analysis
methods are being used to define cellular subsets within tumors to address biological and therapeutic
questions. However, the need to first convert tissue into single cells is a significant barrier to more widespread
use, particularly in clinical settings. Current tumor dissociation methods are long, inefficient, and not
standardized. Moreover, there remains a question as to whether certain cell subtypes are easier to release
than others, which would bias results. In previous work, we developed novel microfluidic devices that utilized
hydrodynamic forces to break down tissue into single cells. We have already shown excellent performance
using in vitro tumor cell aggregates and mouse organs, significantly enhancing single cell recovery and
decreasing processed time. In this proposal, we will develop an integrated microfluidic platform that will
radically change the way tumor tissue is dissociated into single cells, and thus facilitate single cell diagnostics.
This will involve four separate microfluidic device technologies that we have pioneered in published or
preliminary work. These devices were designed to work sequentially, with each operating at a different size
scale starting from tumor tissue specimen (Digestion), through large aggregates (Dissociation) and clusters
(Filter), and finally eluting a suspension of 100% single cells (Acousto-Elution). Any remaining cell clusters will
be recirculated back into the front end of the device to maximize cell recovery. Single cells will be continuously
eluted from the system as soon as they are ready, within minutes after dissociation, to prevent over treatment
and maintain viability. We will first develop and optimize each device separately using human breast,
pancreatic, and prostate tumor tissue specimens. Next we will integrate all devices into a versatile system that
will operate one, multiple, or all devices, as well as establish continuous processing. Finally, we will rigorously
evaluate suspensions using single cell RNA sequencing (scRNAseq) to assess whether cell sub-types are
biased by any device component and/or elute with different time-courses under continuous processing. The
Specific Aims for this 3 year project include: (1) optimize microfluidic devices using human tumor tissue
specimens, (2) develop the Acousto-Elution Device, (3) integrate all devices and establish continuous
processing, and (4) evaluate device processed cells for biasing and elution dynamics using scRNAseq. Our
microfluidic device platform technology will directly impact single cell analysis of tumor tissues, including the
emerging and potentially transformative method scRNAseq. Penetration of scRNAseq into clinical settings
would help usher in an era of precision molecular medicine by providing an initial survey of the cellular
landscape for prognostic and therapeutic signatures. Our device will advance these goals by automating the
dissociation workflow, increasing efficiency, minimizing tissue pre-processing, eliminating bias, and
continuously eluting single cells.

Public health relevance
Public Health Relevance Statement New diagnostic methods are needed that can assess the cellular diversity and complexity of solid tumors. Single cell sequencing holds potential to fill this role, but the technical challenge of extracting cells from tumor tissue remains a major barrier. The proposed project will address this challenge by combining multiple microfluidic technologies into platform for processing tumor tissue into single cells in a rapid and efficient manner. The microfluidic devices will each be tested using human tumor tissue, and then integrated into a single platform amenable to clinical operation.